COCAINE PET EFFECTS ON BRAIN METABOLISM AND DOPAMINE D2 RECEPTORS

This project studies the pharmacological and behavioral tolerances to chronic I.V. cocaine use and to determine the acute effects of I.V. cocaine on cerebral blood flow.